Targeting Barriers to Pain Self-Management in Women Veterans: Refinement and Feasibility of a Novel Peer Support Intervention (Project CONNECT)

Background. Women are the fastest-growing segment of Veterans Healthcare Administration (VA) utilizers.
Although men and women Veterans both report high rates of chronic pain, rates are higher in women.
Addressing their unique needs is a priority. VA has placed renewed emphasis on promoting self-management
for pain. Despite having a widely supported program for doing so, cognitive behavioral therapy for chronic pain
(CBT-CP), several barriers to accessing this care and engaging optimally with its recommendations are noted
and these may be particularly salient for women. These include logistical, healthcare delivery, and
psychosocial barriers. Patient-centered efforts to address these in the context of evidence-based pain
interventions, like CBT-CP, may translate to improved treatment access, engagement, adherence, and more
optimal outcomes for women Veterans. Accordingly, a home-based, intervention integrating an evidence-
based CBT-CP program with reciprocal peer support (RPS) has been developed (CONNECT) and is currently
being pre-piloted. Results are promising but substantial refinement and feasibility testing is warranted before a
full-scale trial is warranted. This proposal will optimize the feasibility and acceptability of CONNECT and
examine the potential feasibility of candidate control conditions for a future randomized trial.
Significance/Impact: Because CONNECT is less resource-intensive than CBT-CP and because it is home
based, it may reduce costs and improve access to behavioral pain care, and its success may have implications
for male Veterans with pain. It targets previously unaddressed and potentially modifiable factors (e.g. social
support) thought to be relevant for adjustment and uptake of pain self-management among women Veterans.
Innovation: CONNECT examines an alternate method for promoting CBT-CP that is potentially scalable, cost-
effective and transportable. Specific Aims: Aim 1a. Solicit Veteran feedback on the refined recruitment
strategies, treatment components and materials, duration/content, engagement strategies peer-matching and
data collection methods. Aim 1b. Evaluate the feasibility (retention, adherence, assessment methods,
recruitment rate) and acceptability (credibility, satisfaction) of a refined 8-week RPS pain self-management
intervention (CONNECT) in a sample of 30 women Veterans with chronic musculoskeletal pain. Aim 1c:
Conduct a responder analysis to classify the percentage of women Veterans that evidence clinically
meaningful improvements in pain intensity/interference and depressive symptoms. Aim 2: Use qualitative
methodology to a) examine participant perceptions regarding satisfaction/acceptability of CONNECT, and of
specific components, and b) examine participant perceptions of underlying mechanisms. Aim 3: In preparation
for a future randomized-controlled trial (RCT), conduct a feasibility analysis to determine preferences for
treatment using the prospective preference assessment, which includes a) qualitative interviews to query
motivations for, concerns about and factors influencing participation in a future RCT as well as survey
measures to assess b) willingness to be randomized to candidate control conditions, and c) factors influencing
their willingness. Methodology: A single arm pilot design and an analogue study to examine the feasibility of
randomization to candidate control conditions. Next Steps/Implementation. If CONNECT is feasible a Hybrid
Type 1 trial will be warranted to determine whether providers may confidently recommend CONNECT to
women Veterans and to examine implementation factors.

Public health relevance
Women represent the fastest growing segment of VA utilizers and over 75% report chronic pain. Developing gender-sensitive VA pain care programs to meet the unique needs of this population is a priority. Nationally, there is renewed emphasis on promoting pain self-management to improve quality of life and to reduce reliance on potentially risky medication regimens. At present, VA has a highly effective behavioral pain self- management program, cognitive behavioral therapy for chronic pain (CBT-CP), but logistical, healthcare delivery and psychosocial barriers make it difficult for women Veterans, in particular, to take advantage of it. Accordingly, a novel home-based intervention integrating CBT-CP with peer support was developed (CONNECT). The proposed study will determine whether CONNECT is both feasible for and accessible to women Veterans with chronic pain while evaluating the feasibility of candidate control conditions for a future effectiveness trial. .